Sensation and Psychiatry: Linking Age-Related Hearing Loss toLate-Life Depression and Cognitive Decline

Age-related hearing loss (ARHL) is the third most common health condition affecting older adults after heart disease and arthritis and is the fifth leading cause of years lived with disability worldwide. The prevalence of clinically significant hearing impairment rises steeply with age, from 3% among adults 20-29 to 49% of adults ages 60-69 and over 80% in individuals 85 years of age and older. Many hearing-impaired older adults avoid or withdraw from social contexts in which background noise will make it difficult to communicate, resulting in social isolation and reduced communication with family and friends. Social isolation and loneliness have been linked to numerous adverse physical and mental health outcomes, including dementia, depression, and mortality, and they may also lead to declining physical activity and the development of the syndrome of frailty. Neuroimaging studies of ARHL have begun to elucidate the brain changes associated with degraded auditory input that provide plausible pathways by which chronic hearing loss may cause cognitive dysfunction and affective dysregulation. In this project we hypothesize that untreated ARHL represents a distinct pathophysiologic route to developing Late-life Depression (LLD) and that individuals with comorbid ARHL/LLD are unlikely to respond to treatments (i.e., antidepressant medication) that do not treat the underlying hearing problem. Initial studies suggest remediation of hearing loss using hearing aids or cochlear implantation may decrease depressive symptoms acutely and over the course of 6 to 12 months follow-up. However, the clinical significance of these findings is obscured by lack of rigorous control groups, failure to objectively document hearing aid compliance, and enrollment of study populations lacking syndromal depression or even a threshold symptom score. We propose to conduct the first clinical trial possessing these design features, while also incorporating neuropsychological and neuroimaging assessments that allow us to elucidate predictors and mechanisms of treatment response. 40 individuals will be recruited who are aged ≥60 years, diagnosed with a clinically significant depressive disorder, and have moderate ARHL with impaired speech discrimination. Comprehensive baseline psychiatric, audiometric, neuropsychological, and functional assessment will be performed in addition to structural MRI (white matter hyperintensity [WMH] estimation and grey matter morphometry), diffusion imaging with tractography, and functional MRI (resting state connectivity within the CCN). Participants then will be randomized to receive antidepressant medication (AD) treatment plus bilateral hearing aids (AD + hearing aids) or antidepressant medication plus sham hearing aids (AD + sham) over a 12- week prospective trial. The baseline evaluation, including MRI scanning, will be repeated at the study endpoint. Data from this study could suggest a novel therapeutic strategy for LLD and thereby mitigate its public health burden, while also contributing to the increased recognition and treatment of ARHL more generally.

Public health relevance
Age-related hearing loss (ARHL) is the third most common health condition affecting older adults and is linked to numerous adverse physical and mental health outcomes, including dementia, depression, and development of the syndrome of frailty. The goal of this proposal is to examine whether adding hearing aids to antidepressant treatment is helpful for older adults with combined ARHL and depression.